Investigating structural and biochemical factors guiding concanamycin A biosynthesis

Proposal Summary
Bacteria produce a wide array of diverse natural products through secondary metabolism. Polyketides stand out
in this group of metabolites owing to their remarkable chemical complexity and varied bioactivities. This
fascinating group of natural products includes FDA-approved antibiotics, antifungals, immunosuppressants, and
many other therapeutic agents. Concanamycin A (CMA) is one such polyketide natural product that was recently
found to inhibit the activity of Nef, a Human Immunodeficiency Virus (HIV) protein that blocks normal immune
signaling in infected cells. Following treatment with CMA, cells with active HIV infections can properly relay
immune response signals. Because of its therapeutic potential in combating HIV infections, a thorough
understanding of the systems by which CMA is produced and assembled is needed, as it will help us develop
analogs with improved pharmaceutical properties. CMA is produced by several members of the Streptomyces
genus of bacteria, where the bulk of its biosynthesis is undertaken by a Type I assembly-line polyketide synthase
(PKS) complex comprising 14 functional modules that build the initial CMA precursor polyketide through the
stepwise addition of acyl units. Components of Type I PKSs, from individual enzymatic domains to entire
functional modules, have been structurally characterized in the past. However, the native higher-order
arrangement and interactome of PKS complexes within bacteria remains to be discovered. Similarly, how
nascent CMA precursor molecules are tailored and stored following their biosynthesis remains unknown. To
address the aforementioned knowledge gaps, I propose (1) elucidating the architecture of the concanamycin-
producing PKS complex directly within cells (i.e., in situ) using cryo-electron tomography, cross-linking mass
spectrometry, and integrative modeling and (2) determining key players in CMA storage, and their impact on
CMA tailoring, by pulldown of CMA-associated proteins using CMA-based molecular probes and subsequent
quantitative proteomics, coupled with liquid chromatography-mass spectrometry (LC-MS) analysis of gradient
fractions of CMA-producing cell lysate and high-resolution infrared nanospectroscopy analysis of CMA-
producing cells. The proposed work will provide the first high-resolution structural insights into the PKS
machinery in situ and an improved understanding of CMA biosynthesis, with downstream applications in the
engineering of PKS systems towards producing novel polyketides. I also expect this research to broadly apply
to understanding the biosynthesis of other pharmaceutically relevant polyketides. Finally, understanding
polyketide tailoring and storage will reveal critical insights for improving CMA production, which is necessary for
derivatization to produce other analogs and downstream applications.

Public health relevance
Project Narrative Concanamycin A (CMA) is a polyketide natural product produced by several bacterial species with major potential therapeutic applications. The proposed work will focus on elucidating the structure of the cellular machinery that synthesizes CMA and uncovering the mechanisms behind intracellular CMA storage. Insights from this work will inform strategies for engineering CMA biosynthetic pathways and enhancing the production of CMA and its analogs for therapeutic applications.